Fine-Scale Genome Folding Relative to Transcription and Location

ABSTRACT
The human genome is precisely folded into various structures, which provides the context for functional
processes in the nucleus. Recent advances have indicated the presence of chromatin compartments, CTCF
loops, and small gene-loops as prevalent features of genome organization. Our investigations at high resolution
reveal the presence of sub-genic discordant compartments, placing the 5’ and 3’ ends of many genes in opposite
compartment states. These, along with gene-loops, are highly correlated with transcription elongation status, but
how transcription influences these sub-genic structures is unknown. Additionally, the spatial location of these
features is an important aspect of genome organization that is largely ignored, and which of these features are
dependent on radial location is unclear. The goals of our research are to determine the relationship between
transcription and sub-genic scale chromatin organization and to elucidate the impact of spatial location on
chromatin folding. We will accomplish these goals in programs that use (1) basic mechanistic interrogation to
track how sub-genic structures change as transcription progresses, (2) software development for increased
sensitivity and quantitative fidelity in fine-scale compartment analysis, and (3) investigative genomics to enrich
for peripheral interactions and define the relationship between chromatin contacts and radial position. The results
of this research will resolve mechanistic questions surrounding transcription and gene folding, provide new sorely
needed and cost-saving tools for fine-scale analysis, and identify spatially dependent chromatin organization.

Public health relevance
PROJECT NARRATIVE The overarching mission of our research is to elucidate how transcription and spatial location influence fine-scale features of genome folding. We will accomplish this goal by using both established and innovative genomics and bioinformatics to track the progress of chromatin interactions during transcription and in nuclear space. This work will resolve long-standing mechanistic questions and provide new computational and wet-lab tools for investigating genome architecture at unprecedented resolution.